Modulating mitochondrial calcium in cardiac homeostasis and disease

Project Summary/Abstract
A leading cause of death worldwide, heart failure is often linked to deficits in energy production in
mitochondria. Mitochondrial uptake of cytosolic Ca2+ plays a critical role in matching energy production to
demand by stimulating ATP production. However, mitochondrial Ca2+ in excess can lead to permeability
transition pore opening and potentially cell death. Animal models of heart failure more closely akin to heart
failure with reduced ejection fraction (HFrEF) are linked to increased mitochondrial Ca2+ in some studies and
decreased mitochondrial Ca2+ in others; even less is known regarding the role of mitochondrial Ca2+ in heart
failure with preserved ejection fraction (HFpEF). With the long-term goal of helping to develop therapies to limit
or restore mitochondrial Ca2+ when appropriate to improve clinical outcomes in HFrEF and HFpEF, this
application will map out the contribution of increased and decreased mitochondrial Ca2+ to cardiac dysfunction
in homeostasis and in mouse models of pressure overload and high fat/high sucrose diet with L-NAME.
Tamoxifen-inducible cardiac-specific deletion of Micu1, the gene encoding the “gatekeeper” of mitochondrial
Ca2+ uniporter complex (mtCU), will be used to induce mitochondrial Ca2+ overload. In the same manner,
deletion of Emre, the gene encoding the essential regulator of the mtCU, will be used to eliminate mtCU
activity and lower mitochondrial Ca2+. The overall objective in this application is to systematically compare the
effects of increased and decreased mitochondrial Ca2+ on measures of cardiac health – mitochondrial function,
tissue histology, contractility before and after stimulation – in homeostasis and in two different types of induced
heart failure. The central hypothesis is that elevated mtCa2+ impairs heart function in homeostasis and in
HFrEF, whereas lowered mtCa2+ has negative effects in energetically demanding states and in HFpEF. The
rationale is that based on the literature and our preliminary data, pressure overload forces the heart to work
harder, elevating mitochondrial Ca2+, while some indications suggest that mice fed the high fat/high sucrose
diet with L-NAME have lower mitochondrial Ca2+. Hence, in the former conditions, increased mitochondrial
Ca2+ is detrimental, and in the latter, decreased mitochondrial Ca2+ is detrimental. The central hypothesis will
be tested by pursuing two specific aims: 1) Assess how elevated and reduced mitochondrial Ca2+ impact
cardiac homeostasis; and 2) Assess how elevated and reduced mitochondrial Ca2+ impact HFrEF and HFpEF-
MetS. This research is conceptually innovative in using genetic manipulation to modulate mitochondrial Ca2+,
and in directly comparing elevated and reduced mitochondrial Ca2+ in models approximating HFrEF and
HFpEF. The outcomes of this research are expected to be significant by establishing a new paradigm
regarding mitochondrial Ca2+ in HFrEF and HFpEF, with the potential to inform future therapeutic strategies.

Public health relevance
Project Narrative The proposed research is relevant to public health because it thoroughly tests how perturbations in cardiac mitochondrial Ca2+ impact the heart’s ability to produce energy and pump. By establishing the effects of cardiac mitochondrial Ca2+ increase and decrease on mitochondrial and organismal function in homeostasis, the proposed work represents a conceptual advance towards the NIH’s goal to gain fundamental knowledge of living systems. Furthermore, testing the effects of mitochondrial Ca2+ increase and decrease in two distinct mouse models of heart failure, and discerning when elevated or reduced Ca2+ is deleterious or beneficial, paves the way for significant progress in the NIH’s mission to reduce illness and disability.